Facilitating islet implantation and engraftment following transplantation using primed umbilical cord mesenchymal stem therapies and focused ultrasound

PROJECT SUMMARY
In both autologous and allogenic islet transplantation, islets need to pass through the following steps: Step 1 -
Isolation: When islets are extracted from the pancreas, they are subject to chemical and physical digestion steps
that places them under significant stress, leaving them in a “fragile state” with metabolic dysfunction that makes
them highly susceptible to any further injury. Step 2 - Implantation: When delivered into the liver via infusion into
the portal vein, islets encounter a relatively hostile microenvironment which is hypoxic and contains high
concentrations of metabolites, as well as being subject to an instant blood-mediated inflammatory reaction
(IBMIR) that involves activation of the complement and coagulation cascades. Step 3 - Engraftment: Once islets
settle within hepatic sinusoids, they need to remodel the extracellular matrix (ECM) and form new connections
with the host tissue as well as develop a new vascular supply from branches of the hepatic artery to meet their
ongoing metabolic demands. Unfortunately, these processes collectively place significant stress on islets,
resulting in almost 60% of them being lost within the first 2-3 weeks following transplantation. One promising
approach to help rescue and protect islets through these steps is to use mesenchymal stem/stromal cells
(MSCs). Our data supports the use of umbilical cord derived MSCs (UC-MSCs) as an optimal candidate for islet
transplantation, given they can be easily derived and expanded, are relatively homogenous across donors, and
have an enhanced anti-inflammatory and immunomodulatory capacity. However, they unfortunately express
tissue factor (TF) which will reduce their ability to be used with islets when administered into the portal vein given
this will exacerbate the IBMIR. Recently, we developed a novel approach using pulsed focused ultrasound
(pFUS) to reproducibly prime UC-MSCs (pUC-MSCs), resulting in them having an enhanced bioenergetic
capacity, reduced expression of TF and enhanced expression of ECM remodeling and angiogenic factors.
Interestingly pFUS also increases the synthesis and secretion of extracellular vesicles (pUC-EVs; a novel and
clinically scalable cell-free therapy), with these vesicles also demonstrating a reduced ability for activating the
coagulation cascade. We have also demonstrated the ability of pFUS to stimulate islet function and viability, in
addition to priming sites of islet transplantation where sonicated tissue resulted in improved islet engraftment.
Hence, in this proposal, we aim to validate these clinically scalable therapies (i.e. pUC-MSCs and pUC-EVs from
different human donors to ensure reproducibility) and our novel technology (i.e. pFUS for islet and organ priming)
to improve the functionality of isolated islets (Aim 1 – addressing Step 1), their survival following implantation
into the liver (Aim 2 – addressing Step 2), and their subsequent engraftment (Aim 3 – addressing Step 3).
Finally, we will also examine if pUC-MSCs and pUC-EVs can rescue islet function post transplantation, especially
when given directly into the liver via locoregional delivery into the hepatic artery.

Public health relevance
PROJECT NARRATIVE In both autologous and allogenic islet transplantation, islets undergo significant challenges related to their isolation (step 1), implantation (step 2) and subsequent engraftment (step 3) into the liver following portal vein infusion. In this study, we will optimize islet function and survival through all 3 steps, using novel therapies derived from umbilical cord derived mesenchymal stem cells (UC-MSCs) created by sonicating these cells with pulsed focused ultrasound (pFUS) to generate primed cell (pUC-MSCs) and cell-free (pUC-EVs – extracellular vesicles) clinically scalable therapies. In addition, we will examine the ability of pFUS to directly prime islets prior to transplantation, as well as the site of islet transplantation given its ability to modulate the liver microenvironment.